GlyCoSAM: Glycolysis coupled S-adenosyl methionine regeneration for cell-free methylation reactions

Project Abstract – Invizyne Technologies, Inc
Regio- and stereo-specific methylation of natural products and synthetic pharmaceuticals can
dramatically improve their physiochemical, biological, and pharmacological properties.
Biocatalytic methylations are currently limited by the availability of efficient, scalable regeneration
systems for the cofactor S-adenosyl methionine (SAM). We propose a universal in vitro
platform for the regeneration of SAM using only methionine and ribose as inexpensive
feedstocks. Efficient, low-cost SAM regeneration bridges the gap between small scale high-
throughput screening of methyltransferases for novel methylated products and industrial
production of lead compounds, which is hampered by the availability of large amounts of SAM.
Invizyne has developed a bench-scale, enzyme-based, proof-of-concept SAM regeneration
system called SimpleSAM that is able to efficiently convert luteolin to chrysoreriol. In Phase I of
this project we will i) optimize this enzyme cascade for longevity, stability, SAM turnover numbers
and product yield, ii) expand the system to include C-, N-, and O-methylated targets of interest
and iii) replace the currently inefficient ATP regeneration system with a new cell-free cascade to
regenerate ATP from low-cost feedstock. The resulting GlyCoSAM platform will expand the
current toolkit for sustainable cell-free biomanufacturing and enable the scalable production
of methylated natural products, nutraceuticals, and synthetic pharmaceuticals.

Public health relevance
Project Narrative – Invizyne Technologies, Inc Late-stage functionalization of drug molecules by adding methyl (or other alkyl) groups can greatly alter the pharmacological properties by orders of magnitude – the ‘magic methyl effect’ – yet are difficult to achieve chemically. Nature has evolved methyltransferase (MT) enzymes as powerful tools to add specific methyl groups to molecules and Inivzyne’s cell-free S-adenosylmethionine (SAM) regeneration system, SimpleSAM, exploits MTs and SAM regeneration for discovery and industrial production of methylated pharmaceutical chemicals. Completion of this Phase I SBIR focuses on the development of GlyCoSAM, a deployment-ready platform technology for enzyme- based biomanufacturing of methylated chemicals which can ultimately enable production of previously inaccessible pharma- and nutraceuticals via green chemistry.